Wearable Continuous Drug Monitoring Device for Personal Medications in Opioid Use Disorders (CDM-MOUD)

ABSTRACT
LabSys’s objective is to create a transformative wearable patch, designed as a low-cost
Continuous Drug Monitoring Device for Opioid Use Disorders (CDM-MOUD). Our state-of-the-art
patch utilizes a microneedle—so fine that it is painless—to monitor medication levels directly
within the interstitial fluid, a technique that has been shown to reliably mirror blood concentrations.
Our proprietary detection method can secure both sensitivity and specificity of the opioids at
concerned concentration range. This approach promises a leap forward in managing OUD by
providing uninterrupted insights into the effectiveness of treatment protocols. In our upcoming
Phase I research, our specific aims focus on engineering an alpha prototype with fentanyl sensing
capability. This initial model will integrate our patented electrochemical sensor technology with
low-power electrochemical impedance spectroscopy, coupled with seamless wireless
communication for real-time data transmission. This endeavor is not just about technology; it's
about people. As we refine our prototype, evaluating critical factors such as accuracy, response
time, and device longevity, we will engage with the potential customers. We will tailor the patch to
the nuanced needs of customers to ensure our product aligns with the real-world demands. Our
vision extends into Phase II, where we will further adapt our prototype for broader clinical use,
pursuing the FDA's “Breakthrough Devices Program” participation to meet rigorous regulatory
standards, and clinical trials to ensure the highest standards of patient safety and product efficacy.
LabSys's mission through this project is to empower individuals battling OUD with discreet,
continuous health monitoring, as essential as a glucose monitor. Our products will empower
patient-centered care, fostering better outcomes and facilitating a more personalized approach to
treatment. We believe that our CDM-MOUD has the potential to revolutionize opioid treatment
and offer a new beacon of hope for millions affected by the opioid crisis, particularly,
disadvantaged populations in low-resource settings.

Public health relevance
PROJECT NARRATIVE Drawing from the urgent need to address the opioid crisis, our research aims to develop a wearable opioid sensor to continuously monitor drugs in body fluid for treatment of opioid use disorders. By facilitating personalized medication management and reducing the need for frequent clinic visits, this sensor can improve treatment adherence and accessibility, especially in underserved regions. The proposed technology has the potential to transform treatment protocols and patient monitoring, ultimately reducing fentanyl-related overdoses and fatalities.